The TRECK Program Supplement: Trauma REsearch Capacity Building in Kilimanjaro, Tanzania Program Plan Supplement

Project Summary/Abstract
Every year, nearly 5 million people die from injuries and hundreds of millions more sustain non-
fatal injuries that require medical attention within low and middle income countries (LMICs),
accounting for 90% of all injury-related deaths. Reducing the burden of injury requires a quality
trauma care system; these systems are poor with limited services in LMICs like Tanzania.
Optimizing care at each step along this continuum requires implementation research strategies
and a network of like-minded, invested stakeholders. This training program will train postdoctoral
research fellows and KCMUCo faculty members on Implementation Science (IS) methods to
address the current need for expertise in the region. This supplement will build on our parent D43
TRECK training program, which identified the current gap in IS capacity at Kilimanjaro Christian
Medical Center University College (KCMUCo). Moreover, this supplement will build on Kilimanjaro
Christian Medical Center and Duke University’s long-standing collaborations for capacity building
(MEPI/HEPI, D43s) and injury research (R21 and R01) level projects. The goals of this proposal
are two-fold 1) to strengthen KCMUCo IS expertise through the training and mentoring of
Tanzanian TRECK fellows and 2) to collaboratively redesign the KCMUCo Epidemiology and
Applied Biostatistics research practicum at KCMUCo to include IS tenets, and train KCMUCo
faculty on IS core concepts.

Public health relevance
Project Narrative Recent work shows that low middle income country trauma systems are limited by patient-payer models, limited personnel with specialized focus, high cost services, very limited access to care, and few specialists with adequate implementation research training to translate knowledge into practice to create and apply implementation science strategies. Optimizing care at each step along this continuum requires a rigorous, patient-centered, and health system–contextualized implementation research strategy and a network of like-minded, invested stakeholders. The objective of this supplement is to strengthen local capacity to train and supervise implementation science postdoctoral researchers and activities, by investing in the professional development of educators and collaborators at Kilimanjaro Christian Medical College and University, as well as expanding professional development activities.